Expanding Access to Pregnancy Specific Opioid Use Disorder Treatment in Jail: Piloting and Adaptable Implementation Strategy to Advance Equitable and Patient-Centered Care

Project Summary/Abstract
Nearly 2 million women pass through U.S. jails each year, with nearly 8,000 admissions of pregnant people
with opioid use disorder (OUD). Providing evidence-based treatment to these individuals is essential to
addressing the opioid epidemic, to optimizing maternal and newborn outcomes, and to promoting maternal
health equity. There is increasing recognition of the critical role of jails in providing access to medication
treatment for opioid use disorder (MOUD) as a means of curbing the opioid epidemic, reducing overdose
deaths, and promoting racial equity for a group of individuals who are systematically marginalized. While there
is a growing number of jails that are expanding access to MOUD, strategies that are specific to the unique
needs of pregnant people are lacking. Moreover, many jails still do not provide MOUD even in pregnancy,
despite the well-established standard of care of avoiding withdrawal and the known benefits of MOUD
specifically for pregnant individuals. Our long-term goal is to ensure that pregnant people with OUD in jails
receive appropriate and timely care to optimize their long-term wellbeing and that of their infants. The overall
objective is to develop and pilot an adaptable implementation strategy and toolkit for jails to be able to provide
access to pregnancy-specific OUD care. The rationale is that jails vary tremendously in size, resources, and
health care delivery systems, and need tools they can tailor to their environment. Ensuring jails provide access
to MOUD, and in ways that are tailored to the distinctive medical, mental health and social structural aspects of
care for pregnant people with OUD is essential for improving short and long-term pregnancy, recovery, and
intergenerational outcomes. This project will engage multiple stakeholders, including directly impacted people,
to design then pilot a patient-centered and jail-feasible implementation strategy that will facilitate and enhance
jails’ implementation of MOUD for pregnant people. The strategy will contain a menu of tools to assist jails with
immediate needs to provide MOUD to pregnant people entering jails; with pregnancy-tailored counseling; and
with other support services and linkages to care that center the obstetrical, psychosocial, and structural needs
of this population. The implementation strategy will also be adaptable to a variety of types and geographies of
jails. They will then be piloted at four jails with different baseline capacities and services for MOUD for
pregnant people. The steps proposed in this R34 are necessary for building the tools, outcome measures, and
capacity that will be scaled-up in a future R01 hybrid implementation/effectiveness trial to improve OUD
treatment access and maternal and infant health outcomes for this long-overlooked group.

Public health relevance
Project Narrative- Public Health Relevance Statement The proposed research is relevant to public health because of the high rates of opioid use disorder among pregnant people in jail and the need to provide evidence-based treatment in order to optimize maternal and infant outcomes. This project is relevant to NIDA's strategic goals to increase access to opioid use disorder treatment for jail populations, who are at high risk of adverse outcomes, and, with NIDA's recently established Racial Equity Initiative, to address racial inequities in substance use treatment. By conducting research and building partnerships with directly impacted individuals and jail policy leaders, we will promote implementation and dissemination of evidence based treatment for pregnant, incarcerated people that will improve outcomes for them and their children.